LifeBioTALK: Digital Engagement with a Pre-Scripted Avatar for People with Alzheimer's Disease to Reduce Challenging Behaviors and Caregiver Burden

Project Summary/Abstract
LifeBio develops agetech for care management of people with dementia (PWD). In this proposed SBIR
Phase I, we will build out the prototype of LifeBioTALK, a tablet-based platform designed to provide
stimulating and engaging audiovisual content to PWD narrated by a human-like pre-scripted avatar. The
eventual vision for LifeBioTALK is to simulate natural conversation with an avatar narrating audiovisual
episodes with appropriate multimedia content with no need for a human behind the narration. Our work is
predicated on the idea that engaging with appropriate content with simulated human interaction may lessen
the impact of loneliness on the person with AD/ADRD. We anticipate a large commercial market in home
care settings as well as in residential care settings when caregivers are seeking a simple way to engage
PWD. In Phase I, LifeBio will design the LifeBioTALK prototype with six scripted 22-minute episodes
narrated by a human-looking “talking” avatar. The MVP will have the ability to record video and audio
responses from participants and will use the iPad’s built-in TrueDepth camera to collect participant
response data to conduct preliminary objective assessments of engagement with the LifeBioTALK content.
LifeBio will elicit user feedback to finalize a usable prototype. In Aim 2, our collaborators at Brown
University Division of Geriatrics will conduct a fidelity trial with 35 dyads (a person with dementia and
their care partner) to evaluate acceptability, feasibility, and preliminary efficacy of LifeBioTALK for PWD.
Caregivers will set up the tablet and PWD will watch six 22-minute LifeBioTALK episodes (2 a day x 3
days). The caregiver and PWD will complete the system usability scale (SUS). Feasibility will be
determined by usability scores of >30 (out of 50) on the SUS. Participants will also complete open-ended
feedback questions about the product. Our long-term vision for LifeBioTALK in Phase II is that the
platform will have individualized and varied content that objectively engages the PWD. The fully built out
LifeBioTALK (in a future Phase II) will ‘learn’ to detect when users like or dislike content based on AI/ML
that integrates facial imaging detection. We anticipate that PWD using LifeBioTALK will have a reduction
in challenging behaviors because the experience with the product will promote mental stimulation and
enjoyment and reduce feelings of loneliness. We anticipate the product will lessen caregiver burden by
offering periods of respite while the PWD is engaged with tailored, customized content in Phase II.
Importantly, to promote commercialization of the LifeBio suite of products, the LifeBioTALK will leverage
our NIA SBIR-funded LifeBioMEMORY life story app technology to gather the background, story, and
care preferences stored in LifeBio’s database to expedite customization of LifeBioTALK episodes in Phase
II. We anticipate that this will be a competitive market solution to the well-established finding that social
isolation, loneliness, and challenging behaviors, nearly unavoidable sequelae of AD and ADRD, are the
main drivers of poor quality of life for both the PWD and the caregiver.

Public health relevance
Project Narrative LifeBioTALK aims to address the emotional and psychosocial needs of a person with dementia (PWD) with pre-planned engaging content that may lessen loneliness and the impact of challenging behavior, thereby improving quality of life for PWD while reducing the stress of the caregiver. Commercial markets will include organizations reaching in-home dementia caregivers (health plans, home care) as well as long- term care, assisted living, and memory care.